Physical activity phenotypes and their association with traditional outcomes in pulmonary arterial hypertension

Project Summary/Abstract
Candidate: Jasleen Minhas, MD is a pulmonary and critical care physician-scientist passionate about developing
personalized interventions promoting physical activity to improve patient outcomes in PAH. She seeks didactic
and experiential training to develop expertise in advanced statistical methods for multidimensional data,
longitudinal data analysis, and qualitative methods to advance her career goals towards research independence.
Research Context: Activity limitation is an early manifestation of PAH and often persists despite treatment.
Patients with PAH prioritize the impact of disease on their daily physical activity over its effect on exercise
capacity. However, PAH care focuses on improving exercise capacity as measured by the 6-minute walk test.
Clinic-based tests do not capture the daily variability in functionality. This proposal uses a non-invasive biosensor
device that continuously captures multiple data streams (including ECG, respiratory rate, and activity) to define
the clinical implications of continuously measured cardiopulmonary measures and physical activity in the patient’s
home environment. Additionally, we will assess patient’s attitudes and preferences toward behavioral
interventions targeting physical activity.
Specific Aims: 1) Identify determinants of patterns of heart rate and daily physical activity in PAH. 2) Phenotype
patients by integrating cardiopulmonary and physical activity measures and determine the association of
phenotypes with clinical outcomes. 3) Assess patient attitudes and preferences for activity-based interventions.
Research Plan: Dr. Minhas will utilize data from the ACTiPH-VP study to accomplish these aims. She will
identify predominant patterns of heart rate and physical activity using a multilevel functional principal component
analysis and identify their determinants. She will then integrate cardiopulmonary measures with physical activity
and utilize the Joint and Individual Variance explained method to identify novel phenotypes and investigate their
association with clinical outcomes. For Aim 3, Dr. Minhas will use semi-structured interviews to assess patient
attitudes towards physical activity, and their preferences for activity-based interventions.
Career Development Plan: Working closely with her mentors and advisors, Dr. Minhas’s goals are to 1) expand
expertise in advanced statistical methods and dimensionality reduction techniques for multidimensional data
gathered by biosensor devices; 2) obtain skills to design, launch, monitor and troubleshoot a multisite,
prospective study; and 3) gain proficiency in qualitative methods to elicit patient preferences. Additionally, she will
remain heavily involved with the parent ACTiPH study, gaining skills in startup, oversight, and completion of a
multisite, prospective cohort study of patients with PAH across the US.
Environment: The University of Pennsylvania offers an ideal environment to pursue this training, with well-
established mentors. Her division is heavily invested in Dr. Minhas’s success.

Public health relevance
Project Narrative Pulmonary arterial hypertension (PAH) is a progressive disease with high morbidity and mortality; physical activity limitations are the most common initial presentation. The current research will be the first step in integrating cardiopulmonary measures with physical activity to phenotype patients, investigating the correlation of these phenotypes with clinical outcomes in PAH, and understanding patients’ attitudes and preferences for activity-based interventions. This work will set the stage for a trial of interventions promoting preferred exercise patterns, eventually allowing personalized activity-based prescriptions in PAH.